Heme trafficking in prokaryotic cytochrome c biogenesis

Project Summary
Cytochromes c are highly conserved heme proteins that function in electron transport chains for cellular
functions such as respiration, photosynthesis and detoxification. The ability of prokaryotes to survive and thrive
in diverse, often hostile environments is a direct result of the plasticity of their electron transport chains, of
which cytochrome c is an essential component. Much effort has been devoted to studying the roles of
individual cytochromes c, but much less is understood about their biogenesis, which requires the covalent
attachment of heme at a conserved CXXCH motif for proper folding and function. Despite their diversity, all
cytochromes c are made by one of three pathways, System I (prokaryotes), System II (prokaryotes) and
System III (eukaryotes), thus elucidation of the molecular mechanisms of these pathways is critical to our
understanding of bioenergetics and cellular survival. While the three pathways have evolved different
mechanisms to accomplish biogenesis, all must transport heme to a holocytochrome c synthetase. Heme is an
essential co-factor in all organisms, functioning not only in electron transport chains for respiration, but also for
catalysis, regulation and signaling. Yet our knowledge of heme transporters and heme trafficking is limited due
to heme’s cytotoxicity, the transient nature of trafficking and the technical challenges of studying membrane
proteins. Thus, we must also address the mechanisms of heme trafficking and here we describe our long-term
vision to elucidate the general mechanisms of heme delivery, transport and attachment, beginning with the
System I pathway. We propose to 1) identify the cytoplasmic heme receptor and mechanisms of heme
delivery, 2) determine the path of heme trafficking by System I, and 3) identify the requirements for periplasmic
heme attachment. The System I pathway consists of eight integral membrane proteins (CcmABCDEFGH) and
provides a tractable model system to study these fundamental biological questions. CcmABCD are proposed
to transport heme across the bacterial membrane and attach it to CcmE, the periplasmic heme chaperone,
which trafficks heme to the holocytochrome c synthetase, CcmFH. Utilizing a functional, recombinant E. coli
system, the System I proteins purify with endogenous heme, removing many of the technical barriers often
associated with membrane proteins. Importantly, the heme attachment reaction occurs in the periplasm, is
required for the survival of many pathogens, and likely differs in mechanisms of heme attachment from the
eukaryotic synthetase, thus the CcmFH synthetase is a potential target for novel antimicrobials. Our proposed
studies on System I will simultaneously provide insights into cytochrome c biogenesis and general
mechanisms of heme trafficking, uniquely positioning us to study two fundamental biological processes. A
natural extension of this work is to apply the general principles learned and approaches developed to the other
cytochrome c biogenesis pathways, as well as to other prokaryotic and eukaryotic heme transporters.

Public health relevance
Project Narrative Cytochromes c play an essential role in bioenergetics, functioning in diverse electron transport chains for aerobic/anaerobic respiration, photosynthesis and detoxification, which are critical for bacterial survival. The proposed studies strive to elucidate the molecular mechanisms of cytochrome c biogenesis, specifically heme delivery, trafficking and attachment. Investigation of these pathways will provide insights into two fundamental, yet poorly understood, biological processes, cytochrome c biogenesis and heme trafficking, laying the foundation for future studies on other heme transporters.